Islet & Physiology Core

Project Summary/Abstract (Islet & Physiology Core)
The Islet & Physiology Core supports the overall mission of the Indiana Diabetes Research Center (IDRC) to
promote cutting edge research in diabetes and related metabolic disorders; foster collaboration; and support
training by providing comprehensive and state-of-the art services in rodent islet isolation, rodent and human
islet characterization, human and rodent islet transplantation, and rodent metabolic phenotyping. These
services support research initiatives aligned with core Scientific Goals outlined in the NIDDK Strategic Plan for
Research by: 1) advancing the understanding of contributors to health and disease; 2) developing innovative
technologies and resources to advance scientific progress, and 3) bolstering the pipeline of research
investigators by enhancing development and training for both basic and translational scientists. The Islet &
Physiology Core supports the work of IDRC investigators from Indiana University School of Medicine (IUSM)
and its affiliated institutions, working closely with members to provide “wrap-around” services that include
assistance with experimental design, efficient execution of experiments, and support for data analysis and
interpretation. The Core serves both experienced and novice users and functions as an important conduit for
facilitating entry into the field for investigators who have not traditionally worked with islets or performed
metabolic research. In addition to consultative and experimental services, the Core provides training for
investigators who wish to incorporate specialized techniques back into their own lab. The Director of the Core
is Dr. Carmella Evans-Molina, and the Associate Director is Dr. Jason Spaeth. The Islet & Physiology Core
closely interfaces with the IDRC Translation, Microscopy, and Data & Analytics Cores to meet the experimental
needs of our User base, while adhering to the highest standards of rigor, reproducibility, refinement, and
reduction. The Islet & Physiology Core will achieve the following aims:
(1) Provide IDRC investigators with high quality rodent islets and facilitate the procurement of human
pancreatic tissues for analysis.
(2) Provide state-of-the-art human and rodent islet and pancreas characterization services.
(3) Provide services for rodent metabolic analysis, including assessment of glucose and insulin
tolerance, body composition, energy expenditure, activity levels, and food intake.
(4) Provide consultation services and training that is tailored to fit the needs of both experienced users
and users who are new to diabetes and metabolic research.
(5) Ensure that Core services evolve to meet IDRC investigator needs and keep pace with new
developments in the field.